Elucidation of the regulation and function of innate lymphoid cells

PROJECT SUMMARY
Innate lymphoid cells or ILCs are recently characterized constitutes of vertebrate immune system. They share a
common lymphoid progenitor in bone marrow with T and B cells but lack antigen-specific receptors. ILCs localize
in many tissues of both mice and humans but are enriched in barrier surfaces such as lung, gut and skin, where
they directly respond to ‘alarmin’ cytokine signals released from inflamed or injured tissues. By producing an
array of ‘effecter’ cytokines, ILCs initiate and amplify downstream immune reactions, thus are considered to be
critical early protectors in host defense. Increasing evidence indicates that ILCs also play important roles in tissue
remolding, metabolic homeostasis, inflammation and autoimmune disorders. My research vison is to understand
the biological principles and molecular basis of ILC activation, migration, and their immunological functions.
ILCs were generally believed to be tissue-resident cells and they don’t circulate even during infection. But this
major concept of ILC has been completely changed by my recent discovery of a new ILC population, termed
inflammatory or induced ILC2s, which migrate from the gut to the lung during helminth infection. Those findings
establish a new paradigm of ILC biology: though ILCs, or ILC2s at a minimum, are largely tissue resident in the
steady state, they become mobile during infection and contribute to distal immune protection. With this new
paradigm, many fundamental questions on ILCs are to be answered. In the proposed five-year project, we aim
to answer a few: 1) Do intestine-derived ILC2s modulate asthma? We hypothesize that repositioning of gut-
derived iILC2s to the lung during parasitic infection dampens the allergic responses by conferring ‘innate
tolerance’ to stronger asthmatic allergens. 2) Does microbiota modulate ILC2 activation and migration? We
hypothesize that intestinal microbiota is essential for cytokine-induced ILC2 responses and commensal bacteria-
derived metabolites provide a secondary signal that facilitates ILC2 activation and subsequent inter-organ
trafficking. 3) Do existing drugs that target T cells have the capability to regulate the ILC function? We will perform
a screening assay to identify such candidate drugs by using a gene reporter system that we have generated.
Successful completion of the proposed studies will lead to a fundamental understanding of molecular
mechanisms that underlie ILC2 activation, ILC2 migration, ILC2 repositioning-mediated protection against
allergic asthma, and microbiota-ILC2 interaction. The knowledge to be gained will contribute to the development
of novel therapeutic approaches for asthma and other inflammatory and infectious diseases. The existing drug
screening will enhance the reconsideration of drug usage in clinic. Multi-disciplinary approaches will be employed
including high-parameter flow cytometry, single-cell(sc) RNA-Seq, scATAC-Seq, multiplex 3D tissue imaging
and genetic mouse models. This is a research complex of immune cell biology, molecular biology, system
immunology and host-pathogen interaction. Columbia University Medical Center provides enormous research
resources and great opportunities for collaborations that will make it possible.

Public health relevance
Project Narrative Innate lymphoid cells are relatively poorly understood immune cell populations that play important roles in host defense, inflammation, allergic responses, tissue remodeling and metabolic homeostasis. Our research goals are to understand the fundamental biology of innate lymphoid cells, including their immunological and nonimmunological functions, molecular mechanisms of their regulation and migration, and their interactions with both pathogenic and commensal bacteria. Knowledge gained from these studies is expected to lead to the significant development of new therapeutic strategies for infectious, allergic and metabolic diseases.